Shared Resource-Functional Genomics and Genome Sequencing Core

Functional Genomics and Genome Sequencing Core Shared Resource - Project Summary/Abstract
The mission of the Functional Genomics and Genome Sequencing Core is to facilitate cutting-edge genomics
research at the Salk Institute by providing: 1) cost-effective and rapid high-throughput sequencing services, 2)
expert assistance in experimental design, and 3) the development of novel methods to enable cutting edge
sequencing technologies. In addition, the Core prepares sequencing libraries and performs quality control to
ensure that high-quality data are extracted from each experimental sample. In the near future, the Core will
acquire and implement a single cell sequencing platform. In support of Cancer Center research endeavors at
the Salk, the Core specifically aims to provide: 1) access to state-of-the-art instrumentation for next-generation
sequencing projects, 2) assistance with experimental design when Salk Cancer Center members are seeking
to perform experiments that involve sequencing technologies, 3) novel methods and strategies for
implementing cutting-edge sequencing technologies, 4) preparation and quality control of sequencing libraries,
and 5) training services for Cancer Center members in library preparation or other methods required for next-
generation sequencing projects.